Mechanisms and Consequences of PAX2 Inactivation in the Initiation of Endometrial Carcinogenesis

PROJECT SUMMARY/ABSTRACT
Endometrial cancer represents 7% of all cancer and is the 4th most common cancer in women, with 68,000 new cases
and 13,000 cancer-related deaths anticipated in 2024 in the USA. Annual deaths have been gradually increasing and are
now anticipated to be higher than ovarian cancer. Although surgery can cure early-stage cancers, the 5-year survival of
women with advanced endometrial cancer is <20%. These epidemiologic features should make an improved molecular
understanding of endometrial cancer and new studies to achieve this goal a high priority.
PAX2 is a paired box transcription factor expressed in the developing kidney and reproductive tract. PAX2 is required
for the formation of the Müllerian duct, the embryonic structure which gives rise to the uterus and endometrium. High
PAX2 expression is retained in normal endometrial glands throughout adult life. However, as we and others have shown,
complete PAX2 loss occurs in >80% of all endometrial cancers, making it by far the most common known molecular feature
of early and late endometrial cancers. More interestingly, PAX2 loss appears to be the initiating event as evidenced by 1)
loss throughout most endometrial cancers 2) its equal prevalence in early endometrial precancers vs. fully-developed
invasive or metastatic cancers and 3) the presence of rare PAX2-deficient glands in some normal endometria, arguing that
these minute PAX2-null clones are the earliest precursors from which endometrial cancers arise.
PAX2 mutations have not been identified in genome-wide analyses of endometrial cancer, nor have we found any in
our preliminary studies. Thus, the mechanisms underlying PAX2 loss—and more importantly its functional consequences
in instigating endometrial cancer—are critical questions demanding systematic investigation. We now propose to expand
upon our prior clinical and laboratory observations through wide-ranging state-of-the-art methods to understand the basic
mechanisms of PAX2 loss and its functional consequences in endometrial carcinogenesis.
Our hypotheses are that 1) PAX2 undergoes repression by a specific epigenetic mechanism (gene silencing) and 2)
PAX2 is a functional tumor suppressor through the regulation of the transcriptional landscape within the endometrial
epithelial cells from which endometrial cancers arise. We will explore these hypotheses through diverse experiments aided
by patient tumor specimens, cell line and animal models in a set of three integrated aims, undertaken by a fully committed
team of investigators with complementary areas of expertise.

Public health relevance
PROJECT NARRATIVE Endometrial cancer (also known as cancer of the uterus) represents 7% of all cancer and is one of the most lethal cancers of women. In this project, we propose to study the most common known molecular alteration—PAX2 silencing—driving the formation and growth of endometrial cancer. An improved understanding of PAX2 silencing and its functional consequences will lead to new insights with fundamental implications for future efforts geared towards early detection, diagnosis, prevention, and treatment of this underestimated malignancy of women.